CL 284,846 FOR TREATMENT OF ELDERLY SUBJECTS WITH INSOMIA (TYPE D)

The purpose of this study is to determine the safety and effectiveness of an investigational new drug, Zalaplon (CL-284,846), in comparison to placebo for the treatment of insomnia in older persons.